Shared Resource Core - GUIDeS

PROJECT SUMMARY/ABSTRACT: GUIDeS SHARED RESOURCE
Goals of the Partnership for Native American Cancer Prevention (NACP) include expanding the number of Native
American investigators working in cancer research and increasing the total number of investigators focused on
cancer health disparities within the Native American communities of Arizona. This fifteen-year partnership
between Northern Arizona University (NAU) and the University of Arizona Cancer Center (UACC) has made
significant progress toward these goals, with increasing numbers of successful, early stage investigators (ESIs)
and junior investigators (JIs) engaged in cancer research and cancer health disparities research within the Native
American population. Numerous ESIs and JIs from the earlier years of the partnership have now established
independent research careers with successful academic rank promotions. This success has primarily been
achieved through intentional and collaborative research and career mentoring. In fact, some of the earlier NACP-
associated ESIs and JIs, including Native Americans, now hold leadership positions within the NACP and are
playing a critical role in training the next generation of NACP investigators.
The NACP leadership team for this renewal application proposes to build and expand on the success, learning
experiences, and participant feedback from current and prior project periods by implementing a new-shared
resource called GUIDeS or Guiding U54 Investigator Development to Sustainability. This shared resource will
organize and facilitate a range of new services and career enhancement opportunities, primarily targeted for
ESIs and JIs. The GUIDeS Shared Resource has been strategically designed to interface with the other NACP
components – Outreach, Research Education, Planning and Evaluation, Administrative, and NACP-sponsored
research projects – to ensure services and expertise across NACP are available to ESIs and JIs and that ESIs
and JIs are fully integrated into the full range of NACP activities and research collaborations between NAU,
UACC, and the Native American communities it serves.
Specifically, GUIDeS will: 1) assist ESIs and JIs through the process of developing a rigorously designed cancer
research project and identifying potential funding opportunities; 2) pair them with senior NACP faculty researcher
mentors and other inter-institutional collaborators for the development of their projects and resulting grants and
publications; 3) navigate them through the university system in developing the regulatory, financial, and
institutional requirements for conducting and submitting research to extramural agencies; 4) afford opportunities
to participate in grant development workshops and mock study sections as well as access to grant writing and
proposal development services; 5) provide biostatistics and bioinformatics support services as well as
streamlined access to experts in Native American-based community engagement, specifically regarding
research (Outreach Core); and 6) support their development of effective organizational, time management, and
research communication skills, e.g. seminar presentation and manuscript preparation.